Dissecting the Mechanism of Prion Formation with a Permissive Host

Project Summary Prion diseases are infectious neurodegenerative diseases caused by the induced conformational change of a host-encoded glycoprotein, PrPC, into a pathogenic conformer, PrPSc. Currently, there are no vaccines or therapies available for these invariably fatal diseases, primarily because we do not understand the mechanism of PrPSc formation. Interestingly, there are large differences in host susceptibility to prion infection between different animal species. For instance, rabbits appear to be resistant to all prion strains, while bank voles appear to be a universal host. This variation, which is dependent on PrP sequence, provides us with a unique opportunity to identify the key steps in PrPSc formation shared by all species. Using rigorous biochemical tools developed in our laboratory, we will exploit these naturally occurring differences in host susceptibility to dissect the mechanism of prion replication. Specifically, this powerful comparative biochemistry approach will be used to accomplish the following aims: 1. Directly test the protein-only hypothesis of prion infectivity. 2. Identify and characterize PrPC domains that control susceptibility to prion conversion. 3. Determine whether cofactor molecules and post-translational modifications restrict the host range of prion infection. The results of this project will greatly advance our understanding of the prion replication mechanism. They will also impact our understanding of related, prion-like diseases, such as Alzheimer's and Parkinson's disease.

Public health relevance
Public Health Relevance Prion diseases are fatal infectious diseases that affect a wide variety of animal species, including humans. Outbreaks of prion disease cause an immense damage to public health and the economy, and currently there are no vaccines or therapies available to combat these diseases. The major barrier to drug development is that we do not fully understand the mechanism by which infectious prions replicate. Interestingly, animal species display different degrees of susceptibility to prion infection. For instance, rabbits, horses, and dogs appear to be naturally resistant to infection, whereas the bank vole appears to be highly susceptible to nearly all known prion isolates. In this project, we will exploit the naturally occurring variation in host susceptibility to prion infection to determine the key steps in the fundamental replication mechanism in all animal species. We will do this by using a series of powerful, chemically defined assays developed in our own laboratory to study the replication of infectious prions at the molecular level. This work will provide valuable information the essential composition of infectious prions and the mechanism by which they replicate, which can then be used to design rational targeted therapies against prion disease. In addition, the insights gained here will also influence our understanding of the mechanisms underlying related brain diseases, such as Alzhiemer's and Parkinson's disease.